Connectome and 7T MRI reflect pathologic networks in sporadic primary progressive aphasia and familial FTLD

Clinical research criteria for primary progressive aphasia (PPA) reliably identify semantic variant PPA (svPPA)
and non-fluent/agrammatic variant PPA (naPPA). While statistically associated with underlying pathology,
neither these criteria nor regional MRI atrophy reliably support in vivo diagnosis of frontotemporal lobar
degeneration (FTLD pathology) in an individual with sporadic FTLD-TDP or FTLD-Tau. We propose to identify
macroscale network metrics and ultra-high resolution 7 tesla (7T) MRI profiles that are sensitive to both
regional anatomic features and cortical laminar features in sporadic PPA variants, and we validate our findings
in antemortem imaging of autopsy-confirmed cases and in familial FTLD (fFTLD) mutation carriers with known
pathology. We pursue these goals in three Specific Aims. Aim 1 tests the hypothesis that multimodal 3T
structural MRI (sMRI) and diffusion-weighted MRI (dMRI) networks show distinct graph theoretic metrics in
sporadic svPPA and naPPA that are sensitive to both regional anatomic and laminar-specific features of
disease, and assesses the same features in antemortem MRI of sporadic autopsied cases and in fFTLD
mutation carriers with FTLD-TDP and FTLD-Tau, respectively. We also relate degraded network features to
inexpensive targeted linguistic measures that can screen for disease. This hypothesis is based on findings in
our clinical-pathological series, showing that FTLD-TDP has anterior temporal and orbital frontal pathology
related to sMRI atrophy in the same regions, often in svPPA with impaired naming, and that pathology is
denser in superficial laminae; by comparison, FTLD-Tau has inferior frontal and midfrontal pathology related to
sMRI atrophy, often in naPPA with non-fluent speech, and pathology is relatively denser in deeper laminae. In
Aim 2, we test the hypothesis that partially distinct metrics of progressive disease are seen in longitudinal,
multimodal 3T MRI network of sporadic svPPA and naPPA, and that these overlap in part with network metrics
in antemortem longitudinal imaging of autopsied PPA and fFTLD cases associated with FTLD-TDP and FTLD-
Tau, respectively. Aim 3 examines combined laminar and regional anatomic features more directly by
assessing ultrahigh resolution 7T MRI in PPA and fFTLD cases. 7T MRI is expected to identify relatively
distinct cortical laminar and white matter (WM) features in sporadic svPPA vs. naPPA, and in fFTLD with
FTLD-TDP vs. FTLD-Tau pathology, respectively, and these will overlap in part with distinguishing network
metrics found at 3T. This is based on preliminary findings that ex vivo 7T MRI of autopsied cases shows
relatively distinct, pathology-determined cortical laminar and WM features: FTLD-TDP pathology is denser in
superficial cortical laminae, while FTLD-Tau pathology is relatively denser in deeper laminae and has greater
WM pathology. Novel, pathology-guided, cortical laminar features, combined with regional anatomic markers,
will lay the groundwork for innovative methods to distinguish FTLD-TDP from FTLD-Tau in vivo, and lead to
longitudinal markers for disease progression urgently needed for disease-modifying treatment trials.